Project 1 - Surveillance and monitoring systems to identify strategies to improve perinatal practices [Parent Title: PREVENTING INFANT INFECTIONS WITH IMPLEMENTATION SCIENCE IN MALAWI]

PROJECT ABSTRACT
New HIV infections during pregnancy and breastfeeding represents the last mile in achieving elimination of
mother to child transmission (EMTCT) of HIV. However, little focus has been directed towards structured,
antenatal care based strategies or interventions to prevent HIV acquisition among pregnant and breastfeeding
women without HIV who receive HIV testing in ANC. Pregnant and breastfeeding women in sub-Saharan Africa
(SSA) like Malawi face high rates of HIV incidence. Pre-exposure prophylaxis (PrEP) represents an important
biomedical intervention in the growing fight for EMTCT. With good adherence, daily oral tenofovir disoproxil
fumarate/emtricitabine (TDF/FTC) has been shown to effectively reduce new HIV infections and is considered
safe in pregnancy. Despite oral PrEP promise in reducing HIV acquisition, significant implementation challenges
exist that result in poor adherence and losses to follow up. New PrEP options in the form of the recently U.S.
Food and Drug Administration (FDA) approved long-acting Cabotegravir injectable (CAB-LA) offer more effective
and discrete options that may help address issues of poor adherence. However, the safety data in pregnancy
and breastfeeding remain limited for CAB-LA for PrEP. As women conceive while receiving PrEP for HIV
prevention, obtaining pregnancy safety data for emerging PrEP antiretroviral drugs such as CAB-LA is important
before widespread roll out of the drug in national PrEP programs. The overall goal of this project is therefore to
establish and evaluate surveillance and monitoring systems among pregnant and breastfeeding women exposed
to PrEP (oral PrEP and CAB-LA). Investigators will enroll a cohort of women who are judged to be at high risk of
HIV acquisition categorized according to use of oral PrEP or injectable PrEP. In Aim 1, the investigators will
establish a PrEP pregnancy registry into which all women who begin PrEP during pregnancy or who become
pregnant while receiving PrEP will be entered into a PrEP in pregnancy registry and followed up to their
pregnancy outcome. In Aim 2 the investigators will establish a prospective safety cohort of pregnant women with
PrEP exposure. Women will be followed throughout pregnancy and delivery to obtain their birth outcomes. The
mother-infant pairs will be followed up to about 12 months after delivery. For this aim they also evaluate
acceptability of injectable PrEP and daily use of daily oral PrEP and will also determine whether rates of adverse
pregnancy outcomes (preterm birth, stillbirth, miscarriages) and other clinical outcomes differ according to PrEP
use status (CAB-LA vs. oral PrEP). Aim 3 focuses on assessing the growth and neurodevelopmental outcomes
among the infants exposed to PrEP during pregnancy. Infants exposed to either oral PrEP or CAB-LA will have
nutritional assessments based on World Health Organization (WHO) approved classifications.

Public health relevance
PROJECT NARRATIVE Long acting injectable Cabotegravir (CAB-LA) was recently approved for pre-exposure prophylaxis (PrEP) among at those at higher risk of HIV acquisition including pregnant and breastfeeding women. However, questions remain on the safety of this drugs during pregnancy and breastfeeding population. In this project, we aim to compare the safety of CAB-LA and oral TDF/FTC with respect to adverse pregnancy outcomes and infant development both through a surveillance registry of PrEP users who become pregnant and through an in-depth safety cohort.